Encouraging Multiple PrEP Options for Women Engaged in PRimary Care (EMPOWER)

ABSTRACT
We will adapt and pilot test a technology-enabled, primary care-based, health literacy strategy to
empower women with increased vulnerability to HIV to make informed decisions about PrEP.
Nearly 20% of new HIV infections in the United States (US) occur among cisgender women, with women of color
disproportionately affected. Pre-exposure prophylaxis (PrEP) is a safe, effective, and empowering option for HIV
prevention women can initiate and use without partner negotiation. Yet most women are unaware PrEP is an
option for them. With primary care representing the frontline of healthcare for most adult women, it is an ideal
setting to promote PrEP awareness and informed decision-making. Importantly, women themselves have asked
for PrEP discussions to be normalized in primary care and multiple studies have shown that women value talking
with clinicians about PrEP. Unfortunately, many primary care providers (PCPs) lack the time, resources, and
experience needed to counsel women on PrEP during busy, routine visits. Our proposed R34 Encouraging
Multiple PrEP Options for Women Engaged in PRimary Care (EMPOWER) therefore offers a pragmatic and
innovative approach to the delivery of PrEP information to women in primary care. The EMPOWER strategy
addresses well-documented barriers and `missed opportunities' for HIV prevention among cisgender women and
supports informed PrEP decision-making by: 1) identifying women who may benefit most from PrEP via an
electronic health record (EHR)-based algorithm that utilizes available EHR data on HIV risk factors (i.e. bacterial
sexually transmitted infection, Hepatitis C diagnosis, substance use, intimate partner violence); 2) delivering
understandable, actionable, and non-stigmatizing PrEP education, in multiple formats and languages, directly
and securely to women via the patient portal; 3) enabling women to discreetly self-schedule a visit to discuss
PrEP options with either their own PCP or with a female PCP who has years of experience in PrEP delivery; and
4) supporting PCP counseling via clinical decision support that provides standardized, patient-centered language
to guide PrEP discussions and `smart sets' to facilitate PrEP prescribing, when desired. Our specific aims are
to: 1) Adapt and coordinate the EMPOWER strategy to support informed decision-making among diverse
cisgender women with increased vulnerability to HIV seen in primary care; 2) Pilot test the efficacy of the
EMPOWER strategy, compared to an attention control, on PrEP knowledge, stigma, and future intention to use
PrEP; and 3) Assess the reach, adoption, implementation, and maintenance of EMPOWER components.
EMPOWER will be evaluated in Cook County, an `Ending the HIV Epidemic' priority area. The study will be
meaningfully informed by a community advisory board of diverse women, a scientific advisory board of clinicians
and experts, and a community collaboration board of local organization leaders in the field of HIV.

Public health relevance
PUBLIC HEALTH NARRATIVE To address the significant yet often overlooked problem of HIV among cisgender women, we will adapt and test a multilingual technology-based strategy supporting informed decision-making for PrEP in primary care.